Transforming the BME Design Experience from Freshman to Senior Year

Project Summary/Abstract
Most senior design courses in Biomedical Engineering (BME) challenge students with the task of creating
engineered solutions to unsolved clinical problems. This experience, however, is often the first time in the
curriculum that students are exposed to needs finding, communicating with clinicians, following an engineering
process to generate innovative solutions, and incorporating user feedback. Through the proposed activities, we
will introduce clinical innovation experiences earlier in the curriculum so that BME students enter their capstone
year as experienced innovators. We will capitalize on existing partnerships between medicine, engineering and
business in design, innovation, and entrepreneurship to form an early interdisciplinary BME education that
fosters more experienced and creative biomedical engineers well into the 21st century. Three specific
opportunities for strategic enhancement of the BME undergraduate experience at UAB have been identified.
First, there is a need to create a cohesive experience for BME underclassmen, as student exposure to BME
faculty and content is limited in the first two years. Secondly, there is a large gap in time between the early design
courses and the senior capstone, during which exposure to clinical problems is sparse, and design/innovation
are not emphasized. Thirdly, there is a need for higher level engineering design activities in the capstone
experience. The objective of the present proposal will be met through three aims. The first aim is to introduce to
clinical innovation and design thinking to freshmen and sophomores by providing needs finding opportunities in
a clinical setting and guiding them toward development of solutions to clinical problems in a classroom setting.
In the second aim, ten rising BME juniors will take part in a 10-week summer clinical immersion in which they
will perform needs finding and customer discovery surrounding medical/assistive devices or processes, develop
a preliminary design/prototype, and create a business model. A faculty team will screen their output for use in
the upcoming senior design course. The third aim is to enhancement the senior capstone experience by
accelerating the project selection process and teaching best design practices during the first semester. In the
second semester, new online modules covering business topics will free up valuable class time for advanced
engineering topics and design activities that will improve student learning outcomes and increase the potential
for novel, patentable designs. In addition, we will launch a new effort with the UAB Office of Disability Support
Services (DSS) to recruit students with disabilities into our undergraduate program. People with disabilities
represent a powerful stakeholder and given our record of accomplishment for product development in this space,
this activity will serve to improve overall success and involve an underserved constituent in engineering.

Public health relevance
Project Narrative The objective of the present proposal is to transform the design experience for BME undergraduates at UAB, from freshman to senior year. Activities include a new freshman/sophomore clinical innovation course, a summer clinical immersion for rising juniors, and enhanced design and engineering content in the senior capstone experience. Direct exposure to clinicians and their problems, using clinical matchmaking software developed at UAB, will provide invaluable experiences in needs finding, customer discovery, and the development of engineering solutions that have market potential.